Medication self-administration (MSA) and awareness of MSA: life-relevant markers of cognitive impairment

Project summary/abstract
It is well-understood that life-relevant changes in independence occur as early warnings of
lost cognitive resilience, and eventually Alzheimer's Disease and related dementias (ADRD).
We and others demonstrated that medication self-administration (MSA) provides exactly the
opportunity needed for early identification of ADRD. However, several knowledge gaps
hinder routine assessment of this critical health self-management skill in current care. We
lack studies directly comparing self-reported measures and objective, convenient MSA
assessments in the general population. In addition, the impact of CVD and cognitive risk
factors on MSA errors and MSA overestimation, strong predictors of memory performance
and daily life functional independence, is unclear. To address these challenges, we propose
to perform an objective MSA assessment in the Framingham Heart Study. This cohort has
well-characterized cognitive assessment for up to three decades. An estimated 1185
surviving participants from the second-generation and Omni 1 Framingham Heart Study
cohorts are expected to participate as part of their 11th /6th comprehensive health
examination, starting September 2025. Our central hypothesis is that MSA errors and self-
overestimation are early indicators of disabling brain and behavior changes. In Aim 1, we
will cross-sectionally associate MSA errors and MSA self-overestimation, using the Hopkins
Medication Schedule and a visual vertical scale, with behavioral- (neuropsychological
performance) and brain-based ADRD biomarkers (atrophy, white matter change). In Aim 2,
we will associate MSA assessment with a trajectory of cognitive decline on the Mini-Mental
State (MMSE) and neuropsychological testing, as occurs in ADRD. In Aim 3, we will establish
whether MSA assessment predicts greater care needs and life-relevant disability, examining
the Allocation of Caregiver Time Survey, ER visits and hospitalizations, physical activities, and
physical performance. MSA assessment is brief and feasible, with potentially greater public
health value value than standard generic cognitive screening. We expect that our study will
establish a role for objective MSA assessment in geriatric and cognitive care, and we also
expect our research results to improve the MSA assessment standard used in
pharmaceutical trials that enroll the aged.

Public health relevance
Clinicians lack a standardized, objective measure for assessing an aging person's ability to self-administer their own medications, even though this skill seems to predict cognitive and brain health, as well as limitations on daily life activities and participation. In the community- based Framingham Heart Study, a medication self-administration (MSA) assessment will be administered to detect errors and self-judgements of daily life function. This study will explore how testing MSA actually relates to measures of brain health and changes in thinking that could occur in early Alzheimer Disease, to prove the utility of routine MSA assessment.